SDSU FUERTE: Faculty United towards Excellence in Research and Transformational Engagement

U54 ADMINISTRATIVE SUPPLEMENT SUMMARY
San Diego State University Faculty Unified towards Excellence in Research and Transformational
Engagement (SDSU FUERTE)
The FIRST program is funded through the NIH Common Fund and managed in collaboration by the National
Cancer Institute. The work that will be undertaken through this supplemental funding opportunity is to support
the nine-faculty cohort of SDSU FUERTE (a current U54-funded FIRST Cohort awardee) for their travel to and
participation in the FIRST Annual Grantees Meetings in Spring 2024, 2025 and 2026. The FIRST Annual
Grantees Meeting is a gathering of FIRST MPIs, program staff, NIH staff, and FIRST Faculty to share FIRST
grantees goals, progress, and milestones. The goals for the SDSU FUERTE Faculty (a.k.a. FIRST Faculty)
attendance are to increase collaboration and community among FIRST Faculty, foster an inclusive nationwide
network among the faculty and support their professional development and growth towards independent
researchers and thriving faculty in the academy. The budget includes funding for nine SDSU FUERTE Faculty
to attend the yearly grantee meetings including Air travel, parking, food & per diem, hotel accommodations all
using established rates set forth by the SDSU Research Foundation and within guidelines set by NIH.

Public health relevance
Project Narrative San Diego State University (SDSU) is proposing a new faculty recruitment and retention program called SDSU FUERTE (Faculty Unified towards Excellence in Research and Transformational Engagement). Utilizing innovative, evidence-based strategies to promote institutional inclusive excellence, SDSU will recruit nine early-stage, interdisciplinary, tenure-track researchers who have career goals to address Latinx health disparities in the areas of Addiction Science, Environment Health, and Obesity/Physical Activity/Nutrition.